Structure-based Antiviral Design against HTLV-1 Protease

Project Summary
Human T-cell leukemia virus type-1 (HTLV-1) is an oncogenic human retrovirus affecting over 20 million people
worldwide. HTLV-1 infection can cause adult T-cell lymphoma (ATL) and other serious inflammatory diseases.
Estimates report that 5-10% of HTLV-1 infected patients will develop a serious condition such as ATL, which has
poor 4-year survival and high relapse rates. HTLV-1 has persistent infection rates across the globe and reaches
up to 45% prevalence in certain communities. Despite this impact on human health, there are no direct-acting
antivirals (DAAs) or vaccines against HTLV-1. HIV-1 and HTLV-1 are from the same viral family and encode for
a homodimeric aspartyl protease crucial for cleavage of functional proteins from viral polyproteins. The activity
of HIV-1 and HTLV-1 protease is essential to their viral life cycles. The Schiffer laboratory has extensive
experience with viral protease crystallography and inhibition, especially with viral proteases for HIV-1, HCV
NS3/4A, and SARS-CoV-2 main protease. This expertise uniquely positions me to design, synthesize, and
characterize potent, resistance-thwarting protease inhibitors against HTLV-1 protease. Resistance-preventing
DAA design is essential because of the selective pressure applied during DAA treatment. An ideal and proven
strategy for developing a highly potent and resistance-preventing viral protease inhibitor is to target the active
site through rational design using the substrate envelope. The substrate envelope for HTLV-1 protease has not
been characterized and we lack a detailed understanding of the protease substrate specificity. I hypothesize that
by translating strategies from our design of HIV-1 protease inhibitors, namely characterizing HTLV-1 protease’s
substrate specificity, I can design potent and resistance-preventing DAAs for HTLV-1 protease.
Aim 1: Characterize the structural basis for HTLV-1 protease substrate specificity. HTLV-1 protease
cleaves six substrates by recognizing cleavage sites between individual proteins of the viral polyprotein. I will
investigate the molecular basis of this recognition underlying protease specificity by determining cocrystal
structures of the protease with bound substrates. The conserved volume inhabited by the substrates will define
the substrate envelope and inform inhibitor design for HTLV-1 protease. Aim 2: Rationally design, synthesize,
and characterize inhibitors of HTLV-1 protease to optimize potency. HIV-1 and HTLV-1 proteases share an
active site amino acid sequence identity of 45% and high structural similarity. Therefore, I will begin inhibitor
design by testing a selection of our in-house HIV-1 protease inhibitors, which have already shown low (1 µM) to
moderate (30 nM) potency against HTLV-1 protease. I will combine experimental inhibition assays with cocrystal
structure analysis to identify lead compounds for inhibitor design. I will leverage substrate specificity of the
protease by moving inhibitor design towards compounds that mimic the shape of substrates, leveraging the
substrate envelope (Aim 1), and the interactions between protease and substrate. I aim to produce novel, highly
potent (sub-nM) inhibitors that will be promising DAAs for further investigation against HTLV-1.

Public health relevance
Project Narrative Human T-cell leukemia virus type-1 (HTLV-1) is an oncogenic human retrovirus which has infected over 20 million people worldwide but lacks any vaccines or direct-acting antivirals. I will characterize the substrate specificity of HTLV-1 protease so that I can design inhibitors to mimic substrate interactions with the protease active site. I will design and characterize novel, resistance-preventing, potent inhibitors against HTLV-1 protease using structural and biochemical techniques.